NHLBI - RISK MANAGEMENT FRAMEWORK SERVICES TASK ORDER 1 (TASKS 1 AND 3 WITH OPTIONAL 4, 5, AND 6)

This program has been designed to procure cybersecurity services, including threat detection,
and response that enhances the performance associated with implementing the NIH
Risk Management Framework Services. The outcome is to achieve and maintain
NHLBI information to regulatory FISMA standards, including FISMA reportable systems such as general systems, nine major systems,
and one hundred and fifty sub-systems across the NHLBI intramural and
extramural studies.

The program focuses on three areas: reducing high risks, improving visibility, and
strengthen protections by conducting cyber hunting, monitoring, detecting, and
responding to threats. These areas rely on a foundation of IT management best
practices, including configuration management, patch management, system
administration, operations management, vulnerability management, threat
detection and response, and change management.